Epigenetic mechanisms in a novel model of FSGS

Focal segmental glomerulosclerosis (FSGS) is a pathologic descriptive diagnosis of glomerular scarring
(fibrosis). Many types of kidney injury including inherited mutations, drug toxicity, loss of nephron mass and
autoimmune diseases are associated with this pattern of injury. In some cases, termed primary FSGS, the
underlying insult is not identified. It is likely that a complex interplay between genetic and environmental factors
is responsible for this disorder. However, progress in developing effective therapies for this common cause of
end-stage kidney disease has been hindered by a lack of understanding of the basic molecular mechanisms.
There is compelling evidence that the intrauterine environment and post-natal growth can have significant
effects on kidney function and subsequent development of adult-onset disease. This process, known as
developmental programming, can have far-reaching implications for kidney, cardiovascular and metabolic
function. Significant risk factors of developmentally programmed chronic kidney disease (CKD) and HTN, such
as low birth weight and prematurity, are more common among African Americans, a population that is
disproportionately represented among veterans. A moderate reduction in nephron endowment, which is
typically clinically silent, is a risk factor for FSGS but is not sufficient to cause disease. Additional factors
(“second hits”) determine whether the kidney can adequately compensate for low nephron number or if
maladaptive structural and functional changes lead to disease. Post-natal growth and maturation of the kidney
play an important role in developmentally determined diseases because this period represents a window of
susceptibility to insults (“second hits”) causing permanent morphological changes and functional adaptation.
Recent studies indicate that mitochondrial dysfunction during intrauterine and early post-natal growth may
be a common underlying mechanism for developmental programming of adult-onset diseases such as CKD
and HTN. We discovered that metastases associated protein 2 (Mta2), a core component of the Nucleosome
Remodeling and Deacetylase (NuRD) chromatin-remodeling complex is a critical regulator of genes required
for mitochondrial function and lipid metabolism in the kidney. Deletion of Mta2 in the developing kidney leads to
a moderate reduction in nephron endowment (“first hit”). We posit that the nephrons that do form in the Mta2
mutant harbor epigenetic changes that persist and affect gene expression required for mitochondrial function
and lipid metabolism during post-natal growth and maturation of the kidney (“second hit”). Other metabolic
stressors, such as high fat diet, can also serve as a “second hit” in a susceptible kidney. As a result, the kidney
is incapable of meeting the metabolic and functional demands of post-natal life, leading to FSGS.
We are using cutting edge technologies, such as Hi-ChIP and epigenomic editing, to test a novel paradigm
that the Mta2-NuRD complex significantly alters mitochondrial function and lipid metabolism defining new
mechanisms in the programming of adult-onset disease. Our research team has complimentary expertise in
kidney development and disease, gene regulation, cell metabolism and bioinformatic analysis of mutli-omic
data. Functional defects in lipid metabolism and mitochondrial function during post-natal kidney development
will be examined to define biological processes that drive the development of adaptive (secondary) FSGS. We
will investigate how changes in genomic binding of NuRD and Zbtb7a/b in Mta2 mutants disrupts expression of
genes that regulate cell metabolism in glomeruli and proximal tubules during post-natal maturation of the
kidney. We will identify and functionally characterize genomic enhancers in mouse and human kidney relevant
to FSGS pathogenesis. These genome-wide data sets will be integrated with complementary multi-omics data
in human kidneys (PCEN, KPMP, Nephroseq, Trident) and be of significant value to other investigators in the
field. The long-term goal of our research is to identify early epigenetic events that trigger secondary FSGS
which are amenable to interventions that will prevent or substantially reduce the risk of this disease.

Public health relevance
Every year ~3000-3500 veterans are diagnosed with chronic kidney disease (CKD). In many of these affected individuals there is progressive kidney fibrosis leading to end stage organ failure and a need for dialysis and transplantation. Currently, more than 10,000 veterans are receiving dialysis in the VA health care system. Glomerular diseases, such as focal segmental glomerulosclerosis (FSGS) are a frequent cause of kidney failure. In addition, CKD is a major risk factor for cardiovascular morbidity and mortality. Low nephron number due to congenital renal hypo/dysplasia, premature birth and intrauterine growth retardation (IUGR) significantly increase the risk of glomerulosclerosis, CKD and HTN. These conditions disproportionately affect African Americans, a group that is highly represented among veterans. The proposed research is relevant to public health and to the mission of the VA because the information learned from these studies is expected to provide novel mechanistic insights into FSGS that may lead to therapeutic interventions to prevent the disease.